Understanding GABAA receptor protein folding and misfolding

Project Description
Loss of function of gamma-aminobutyric acid type A (GABAA) receptors is one prominent cause of
genetic epilepsies since they are the primary inhibitory ion channels to maintain the excitation-inhibition
balance in the mammalian central nervous system. Currently, hundreds of clinical variants have been
identified in GABAA receptor subunits, causing their functional defects. Despite the development of
numerous anti-seizure drugs, about one-third of epilepsy patients are resistant to current drug
treatment, and many of them have genetic causes. Therefore, there is an urgent need to understand
the molecular mechanism for the loss of function of pathogenic GABAA receptors as well as to develop
a new therapeutic strategy to correct their function. It has been recognized that reduced surface
trafficking of GABAA receptor variants is one major molecular mechanism for their loss of function. To
reach the plasma membrane to carry out their function, GABAA receptor subunits need to fold and
assemble into pentameric receptors in the endoplasmic reticulum (ER). Many epilepsy-causing GABAA
receptor variants predispose them to protein misfolding in the ER and thus excessive protein
degradation. Recently, we showed that we can correct the function of such variants by restoring their
trafficking to the plasma membrane. Therefore, the overall objective of this proposal is to understand
how cellular degradation pathways remove misfolding-prone GABAA receptor variants; furthermore, we
hypothesize that we can correct the folding of these pathogenic variants to enhance their surface
trafficking and thus function, as a novel strategy to treat genetic epilepsies. Here, in Specific Aim 1, we
will characterize the cellular degradation pathways that remove misfolding-prone GABAA receptor
clinical variants. In Specific Aim 2, we will elucidate a coordinated folding pathway that directs the
protein folding of GABAA receptors in the ER. In Specific Aim 3, we will use small molecules to correct
the folding and thus function of misfolding-prone GABAA receptor clinical variants.

Public health relevance
Project Narrative Genetic epilepsy has a strong linkage to loss of function of GABAA receptors, the primary inhibitory ion channels in the central nervous system. Numerous clinical variants cause protein misfolding and reduced functional surface expression of GABAA receptors. Here, we propose to elucidate the molecular mechanism of GABAA receptor biogenesis and use the principles acquired to correct the function of pathogenic variants, representing a novel strategy to treat epilepsy.